Core 1: Administrative and Bioinformatics Core

ABSTRACT
Dr. Surinder Batra will lead the Administrative and Bioinformatics Core (ABC) as a Program Director. Dr. Batra
will provide oversight of the scientific and administrative activities of the program and chair the P01 Executive
Committee which includes all research project leaders and shared core resource directors (Drs. Hollingsworth,
Singh, Jain, and Thayer). Together, the team will foster communication and collaboration between the research
projects and shared resource cores and monitor and assess progress. Dr. Batra will meet weekly with research
project leaders and shared core resource directors, and he and his staff will serve as the editorial review/clearing
house for all publications resulting from POI activities. The core will plan and coordinate regular seminars, which
will include the project leaders, core directors, and investigators. These seminars will be a part of the monthly
Pancreatic Cancer Program organized through other network programs in pancreatic cancer (SPORE, EDRN
CVC, and TMEN). Core A will encourage, facilitate and coordinate the participation of PPG investigators in
national and international workshops, conferences, and meetings on pancreatic cancer research. Also, Dr. Batra
will coordinate all the activities of the Program including Internal and External Advisory Committees and will
serve as the Program liaison with other appropriate academic units within University of Nebraska Medical Center
and with outside entities. Core support is requested for a Staff Specialist who will be responsible for scheduling
all internal and external meetings, budgetary monitoring, and general administrative assistance. Core A will
provide administrative support for all three research projects and the two shared resource cores. Dr. Jane Meza
will provide supervision for the overall statistical analysis and study design of the program and will lead a team
of biostatisticians that have been assigned to individual projects and cores. Besides, Dr. Babu Guda will provide
bioinformatics support including data mining and comparisons. This is particularly important because some of
the studies proposed in project 1 and 2 will yield a large amount of data from RNA sequencing analysis which
will require the employment of powerful bioinformatics tools to integrate the data and derive meaningful basic
and clinical inferences. Altogether, the scientific and administrative coordination is needed for the success of the
proposed Program where data will come from Research Projects and Cores, and the ABC core is well equipped
to fulfill the administrative and scientific requirements databases through effective management and state-or-art
Bioinformatics approaches.

Public health relevance
Project Narrative Effective administration is essential for the overall functioning, progress and success of the P01 program and Core A will ensure maximal integration of the NCI resources in this program with other programs at UNMC including SPORE, EDRN and TMEN (U54). The administrative core will provide support for the personnel involved in the administration, scientific oversight and coordination, communication, budgetary oversight, and clerical functions associated with the overall research proposed in this Program Project application. Furthermore, Core A will also provide extensive support for the bioinformatics and statistical analyses of the data generated in all the projects.